Extracellular Vesicle Therapy for Diabetic Retinopathy

PROJECT SUMMARY
Diabetic retinopathy (DR) is a leading cause of severe vision loss, affecting nearly 100 million people globally
and over 4 million in the US. Long-standing microangiopathy-driven diabetic macular edema (DME) and retinal
neovascularization (NV) are the major causes of severe vision loss in advanced stages of DR. Thus, inhibition
of aberrant angiogenic factors using an injection of anti-VEGF, steroid, or laser photocoagulation therapy is the
current mainstay for treating advanced DR, however, often fail to resume vision. Since DR remains asymptomatic
until the disease is significantly advanced, screening of early DR and tight control of modifiable systemic risk
factors is a current strategy to manage the early stages of DR. Therefore, developing treatment directly
addressing early pathologic changes in DR, thus preventing visual impairment is a significant unmet need. More
recent studies indicate that diabetes injures the retinal neurovascular unit (NVU) and its interdependent vascular,
neuronal, glial, and immune cells during the development of DR. The long-term goal of our studies is to develop
a new treatment strategy to realign the disrupted neurovascular microenvironment in DR that protects the retina
and visual function. The overall objectives of this application are to test two treatment strategies in DR that
complement each other: 1) active targeting of DR that allows targeted delivery of therapeutic agents to the areas
of retinal vascular dysfunction in its various stages, and 2) intraocular Müller glia-derived exosome treatment to
modulate microenvironment of NVU. Recently, we have shown that exosomes decorated with ASL (ASL-Exo),
composed of Anchor, Spacer, and Arg-Gly-Asp acid (RGD) Ligand-modification actively targets choroidal
neovascularization (CNV). RGD is one of the major ligands and specifically binds a subgroup of integrins that
play an essential role in retinal inflammation, vascular leakage, angiogenesis, and fibrosis in DR. Further, Müller
glia is a major source of neuroprotective and vascular permeability factors, antioxidative activity and epigenetic
modulators. The central hypothesis of this proposal is that bioactive molecules contained in Müller glia-derived
exosomes promote homeostasis of NVU in DR. The central hypothesis will be tested by pursuing two specific
aims. Aim 1 is to evaluate the targeted distribution of intravitreally delivered ASL-Exo to dysfunctional retinal
vasculature in DR. Aim 2 is to determine whether Müller glia-derived ASL-Exo (Müller-ASL-Exo) suppresses DR
by protecting the retina from microangiopathy, inflammation, glial activation, and NV formation and epigenetic
alternation within the retina. The research proposed in this application will test an innovative and novel strategy
that has a great potential to change the current treatment paradigm from passive targeting-directed monotherapy
to active targeting-directed multimolecular target for the treatment of various stages of DR.

Public health relevance
Currently, over 10% of the US population is diabetic. Diabetic retinopathy (DR) is a leading cause of vision loss, affecting nearly 100 million people on a global scale and over 4 million in the US, 1 in 29 persons. The socioeconomic burden from DR is intensified because DR frequently affects the working-age group. The proposed research is relevant to this major public health issue because it focuses on developing a new treatment strategy, active-targeting directed exosome-based biological agents to modulate the neurovascular microenvironment during the development of DR to prevent the progressive disease process and loss of visual function.